Yale Macaque Brain Resource

PROJECT SUMMARY
Because of its close phylogenetic relationship to the human, the non-human primate (NHP) brain holds
enormous potential for understanding structure, function, development and pathology of the human brain.
However, many obstacles impede studies of NHPs (among these, significant logistic, ethical, and financial
burdens). The Department of Neuroscience at Yale University houses a unique collection of brain tissue from
NHP macaques, ranging in age from embryonic to adult, which was generated over almost five decades in the
laboratories of Dr. Pasko Rakic and the late Dr. Patricia Goldman-Rakic. The collection includes sets of slides
with: (1) [3H]thymidine-labeled serially cut brains for cell birth dating; (2) brains labeled with tritiated amino
acids for tract tracing; (3) brains from monkeys with enucleations and selected cortical lesions; (4) brains from
prenatally X-irradiated and ultrasound-exposed monkeys sacrificed postnatally; (5) EM blocks from multiple
brain regions of fetal and postnatal monkeys; and, added in the last year, (6) histo- and immunohistochemically
processed brain tissue and (7) unprocessed NHP brain tissue blocks.
While MBR’s overreaching Specific Aims remain the same, proper adjustments have been made, conducive to
support ongoing research projects and to grow MBR in scope to accommodate new ones. This renewal
proposes: 1) To continue to inventory, catalogue, restore and add materials to MBR Collections 1 to 4. 2) To
histo- and immunohistochemically process tissue to expand collection 6 and to add unprocessed tissue blocks
to collection 7. 3) To continue to advertise and disseminate NHP brain information. 4) To continue to facilitate
use of the resource. A main purpose of the current renewal application is maintain MBR’s operations and to
facilitate its growth by funding the processing of tissue for different neuronal and non-neuronal markers (in M &
F specimens of 7 developmentally distinct age groups) to be added to collection 6. In addition, brain tissue
blocks viable for different treatments will continue to be added to collection 7. The grand objective of this grant
remains the same, to make these unique collections an international research resource that is readily available
to the neuroscience community at-large. If funded, MBR will continue to permit and foster NHP brain research
without requiring additional animal sacrifice. This avoids costly duplication of experiments and unnecessary
use of animals.

Public health relevance
PROJECT NARRATIVE A non-human primate (macaque) brain resource (MacBrainResource, MBR) has been established from slides, tissue and EM blocks generated in the laboratories of Drs. Pasko Rakic and Patricia Goldman-Rakic. This resource will enable scientists worldwide to conduct de novo analyses of the macaque brain at a minimal cost to them and without the sacrifice of any additional animals. To renew MBR for another 5 years would permit the completion of ongoing scientific studies and the initiation of new ones while honoring the public call and scientific commitment to data and resource sharing and a responsible use of animals in research.